Development of Reagents for Sequencing Proteins and Protein Fragments on a Next-Generation DNA Sequencer

? DESCRIPTION (provided by applicant) Proteomics is the study of the structure and function of proteins in biological systems. It has a wide range of applications starting from protein expression profiling in healthy versus diseased states of an organism to analyzing the interaction of proteins in living organisms to mapping of protein modifications and identification of how, when, and where proteins are modified within a living cell. We are developing an approach for the large-scale, massively parallel digital counting of proteins and peptide sequencing based on single molecule detection and a microfluidic platform technology. This revolutionary protein measurement platform will significantly reduce the amount of sample required for analysis and allow identification of low abundance proteins without bias. This innovation will have far-reaching impacts on quantitative systems biology, disease biomarker discovery and validation, clinical diagnostics, and personalized medicine. Pharmaceutical-, reagent supply- and instrumentation companies have paid substantial premiums to acquire technologies that promise to more quickly and efficiently identify targets for both therapeutics and diagnostics. We expect successful release of the proposed instrument will generate substantial revenue in an already growing marketplace.

Public health relevance
PUBLIC HEALTH RELEVANCE There are several components to a proposed ProCure system for the study of the structure and function of proteins in biological systems, including (1) development of the assay, (2) instrumentation, including detection, (3) compatibility of biologicals with material interfaces, including reduction of non-specific background interactions, and (4) software, which includes instrumentation control and bioinformatics. This proposal will focus on component (1), the development of a suitable assay. Specifically, we will describe the experiments needed to optimize split T7 RNA polymerase and produce and test split carbonic anhydrase for use on the ProCure instrument and in the ProCure assay.